Proteomic discovery and characterization of chemical tools that degrade the NuRD chromatin regulatory complex

Project Summary
As virtually all aspects of cell behavior and identity converge upon programmed responses in gene expression,
transcriptional control features centrally in both normal homeostasis and progression to disease. Accordingly,
pharmacologic perturbation of gene regulatory machinery is an attractive approach for understanding and
modulating complex cellular disease states. Transcriptionally targeted drugs must overcome key hurdles,
however, including the limited accessibility of DNA binding factors and multi-component complexes to traditional
drug design approaches, as well as the indiscriminate activity caused by disruption of transcriptional processes
shared across distinct cell types and states. In this proposal, we present and build on a novel discovery of an
immunosuppressive electrophilic chemical probe termed "L4" that avoids these pitfalls through its remarkable
ability to cause selective degradation of multiple NuRD (Nucleosome Remodeling Deacetylase) complex
subunits in a T-cell-restricted manner. Empowered by our laboratory’s recent development of chemical proteomic
strategies to globally map small molecule-protein interactions in native biological systems, we propose a
research strategy to study the mechanism of the unprecedented pharmacological features of L4 and their
implications for broader drug design approaches to target transcriptional complexes. In addition, we will
investigate the relationship between L4-mediated degradation of the NuRD complex and the compound’s
blockade of T-cell activation. In Specific Aim 1, we will apply our group’s chemical proteomic expertise to
characterize NuRD degradation by L4 and map relevant protein targets in human T-cells using a suite of L4-
related compounds and NuRD complex-directed enrichment approaches. In Specific Aim 2, we will evaluate
the role of candidate L4 targets underpinning NuRD degradation using genetic and biochemical approaches and
examine how the identified mechanisms result in the striking features of multi-subunit degradation and state-
dependent (cell type-restricted) activity. In Specific Aim 3, we extend to examine the relationship of L4’s action
on NuRD to its ability to block T-cell activation, and assess and apply this compound as a tool for further study
of T-cell biology. By providing in-depth understanding of the unique pharmacological activity of L4, the proposed
research will contribute to the overarching goals of exploring both novel mechanisms in targeted protein
degradation and state-dependent control of gene regulatory proteins. Together, these broader ambitions
represent promising avenues to overcome challenges in the development of transcriptionally targeted chemical
probes and medicines.

Public health relevance
Project Narrative The development of chemical tools that influence gene regulatory proteins faces challenges arising from recalcitrant target architecture and assemblies, alongside the broad and varied activity of these proteins across different cellular backgrounds. This proposal outlines study of a remarkable small molecule that we have recently discovered to circumvent these challenges by causing coordinated degradation of multiple members of the NuRD transcriptional regulatory protein complex in a T-cell restricted manner. Insight into how this compound produces its unique pharmacological effects should facilitate the development and utilization of novel chemical probes and drugs that target transcriptional regulatory complexes.